BACTERIOPHAGE T4 RI MUTATIONS

Mutagens contribute to the human burden of heritable birth defects and cancer and probably to heart disease as well. Bacteriophage T4 has been widely employed as a model system to analyze mechanisms of mutagenesis. One of the most common T4 mutation assays recognizes r (rapid lysis) mutants by their large, sharply edged plaques. Although the rII mutants are those most often subjected to further analysis, most mutagens produce more rI and rII mutants. Since little is known about rI mutants, we have investigated their general properties. Mutations that produce the characteristic rI phenotype fall into two loci, one the classically described locus at about 1:30 on the standard map and another a locus at about 8:30. Point mutations at the 1:30 locus recombine inter se at low frequencies, suggesting a small gene; several are suppressed by unlinked but as yet unmapped suppressor mutations. The "8:30" locus is being more closely mapped.